Circadian disruption-induced mitochondrial dysfunction in diabetes

Circadian disruption has been strongly associated with diabetes and metabolic syndrome. Recent human studies
implicate β-cell dysfunction as a potential mechanism underlying the increased risk for diabetes with circadian
disruption. It is, therefore, imperative to understand the interaction between the circadian clock and regulation of
β-cell function to prevent diabetes. We have shown previously that genetic disruption of the circadian clock, by
deletion of Bmal1, a non-redundant core clock gene, in mice, leads to β-cell failure and diabetes, secondary to
impaired glucose-stimulated ATP production, uncoupling and impaired glucose-stimulated insulin secretion
(GSIS). β-cells, normally, need to be “metabolically flexible” in being able to switch between substrates for energy
production. However, it is unknown if circadian clock regulates this metabolic flexibility in β-cells. Our preliminary
data suggests that circadian disruption, even for short periods, via an upregulation of Pdk (pyruvate
dehydrogenase kinase), restricts pyruvate entry into mitochondria for oxidation and induces metabolic
inflexibility, and impairment in glucose utilization by the pancreatic β-cells leading to diabetes. The overarching
hypothesis for this proposal is that the circadian clock orchestrates the metabolic pathways in β-cells to ensure
efficient stimulus-secretion coupling. New data from our lab indicates that circadian disruption leads to metabolic
inflexibility in the β-cell wherein it is unable to utilize glucose effectively. We hence hypothesize that circadian
disruption leads to impaired mitochondrial function resulting in impaired substrate utilization, metabolic
inflexibility leading to β-cell failure and diabetes. We will use environmental means to induce circadian disruption
in mice, complemented by inducible and β-cell specific genetic deletion and overexpression models of molecular
clock (Bmal1 and Rev-erb alpha) along with pharmacological and genetic modulation of the molecular clock and
the proposed target pathways including Pdk in human and mouse islets, to test mechanisms underlying the β-
cell failure seen with circadian disruption, especially as it relates to substrate oxidation. We will use
pharmacological interventions to target specific disrupted pathways to restore metabolic flexibility in circadian
disrupted β-cells. The specific aims of the proposal are: (1) To test if circadian disruption leads to mitochondrial
dysfunction and metabolic inflexibility in β-cells, using environmental and genetic circadian disruption models
and investigate if Rev-erb alpha-Pdk axis mediate the circadian regulation of substrate utilization in β-cells. (2)
To delineate circadian clock regulation of mitochondrial function in normal human β-cells and alteration in
diabetic state using loss-of and gain-of-function studies of the molecular clock in normal and diabetic human
islets. (3) Test targeted pharmacological interventions to reverse circadian disruption-induced β-cell
mitochondrial dysfunction. This proposal will decipher the underlying mechanisms of β-cell failure with circadian
disruption in mouse models, test their applicability in human islets and look at targeting specific pathways to
improve β-cell function that lead to therapies to prevent and treat diabetes.

Public health relevance
Project Narrative Circadian disruption (CD) is a strong risk factor for β-cell failure and diabetes. Though we and others have shown the critical function of the intrinsic molecular clock in β-cells, the molecular mechanisms involved in CD-induced metabolic and mitochondrial dysfunction in β-cells are not known. With compelling preliminary data in mouse and human β-cells that identify clock-controlled pathways involved in substrate flexibility and mitochondrial function, successful completion of the proposed experiments will help identify mechanism-based druggable pathways to prevent, mitigate, and reverse CD-induced β-cell failure and diabetes.